Protection against Alzheimer's Disease proteins by novel ubiquitin processes

ABSTRACT Alzheimer's Disease (AD) is highly prevalent, incurable and will continue to grow in impact and reach as our population's age increases. In AD, Aβ and Tau proteins convert from normal protein folding into toxic amyloid conformations. These processes cause neuronal dysfunction and, ultimately, death. Ground-breaking work has been conducted to understand how and why proteins such as Aβ and Tau become toxic and cause neurodegeneration. Still, the etiology of AD remains unclear and solutions for it in the clinic presently elude us. Our laboratory has a long-standing interest in diseases of the nervous system caused by proteins harboring abnormally elongated polyglutamine repeats. Among these diseases is Spinocerebellar Ataxia Type 3 (SCA3), the focus of the currently funded grant, R01 NS086778. In recent work with the causative protein in SCA3 we found that unique processes that involve the small modifier protein, ubiquitin, have suppressive effects. Ubiquitin is best known for its role in targeting proteins for degradation by the proteasome. But, this small protein has many other functions in the cell. Ubiquitination leads to various substrates and mod- ifications, among which are poly-ubiquitin chains that are not attached onto another protein, referred to as unanchored or free chains. We have found that unanchored chains suppress toxicity from polyg- lutamine species, such as the SCA3 protein. Through this application, we propose to extend these observations by investigating the role of free ubiquitin chains in the cellular response against Aβ and Tau in AD.

Public health relevance
NARRATIVE Alzheimer's Disease (AD) is a major and rapidly growing health issue and options to fight it remain elusive. We seek to investigate previously uncharacterized ubiquitin mechanisms to understand the cellular response to proteins that cause AD. Our work will shed light on novel biological processes in AD and other diseases caused by neurotoxic proteins.